Training Program in Molecular Metabolism

ABSTRACT
The Molecular Metabolism Training Program (MMTP) at the Harvard Chan School of
Public Health (HSPH) will train a new generation of academic scientists committed to
conducting cutting-edge research in metabolism and metabolic disease. Central features of this
program include integration of innovative platforms in ‘omics, microbiome analysis, animal
physiology, imaging, and other technologies for analyzing metabolism; unique coursework in
metabolism and metabolic disease, biostatistics, epidemiology, and computational analysis with
a public health focus; and a collaborative faculty based at HSPH and adjacent institutions in the
Longwood Medical Area.
MMTP leverages the innovative training environment offered at a top public health
institution, supplementing it with rigorous training in emerging molecular analysis tools. Trainees
will study both individual and population aspects of disease and other unique resources offered
at a school of public health. The vibrant community of twenty-one faculty mentors studies
multidisciplinary questions such as the interactions between the immune system and exercise or
over-nutrition; the effect of the microbiome on metabolism; the role of lipid drop or mitochondrial
dynamics in metabolic homeostasis; or the effects of metabolic flux on energy metabolism in
well and disease states. Research focuses on understanding the most significant challenges to
global public health, including metabolic syndrome and the related lipotoxic diseases of type 2
diabetes, non-alcoholic fatty liver disease, metabolic diseases of an aging population,
immunometabolism, and immune and microbiome contributions to digestive health.
We are requesting funding for three new predoctoral students and one postdoctoral
fellow every year, so the T32 would support twenty trainees over its five years. Pre-doctoral
students will obtain a PhD in Biological Sciences in Public Health (BPH) from one of the most
highly ranked public health doctoral programs in the nation. BPH attracts a diverse student body
and has a successful track record in supporting these students. Postdoctoral fellows will have
access to coursework, mentors, and a highly interactive metabolism research community.
MMTP will thus train a diverse group of interdisciplinary scientists who can apply innovative
research methods to understand fundamental questions in human metabolism.

Public health relevance
PROJECT NARRATIVE The Training Program in Molecular Metabolism enlists faculty from the of Harvard TH Chan School of Public Health and the Harvard Medical School to provide didactic and research opportunities to trainees interested in a research career in molecular metabolism. We request funding to support 3 students and 1 postdoctoral fellow per year. The program will prepare trainees to apply cutting edge multi-omic, genetic, and physiological methods to advance our understanding of areas including metabolic health and diseases such as diabetes; gastrointestinal health, such as the role of the microbiome; inflammatory and immune effects on health; obesity; and the role of factors such as aging or disease state on metabolic processes.